LOW POTASSIUM DIET EFFECTS ON BLOOD PRESSURE, CNS ACTIVITY AND GLUCOSE TOLERANCE

This projects investigates whether the hypertensive effects of potassium deficiency, and the hypotensive effects of potassium replacement are mediated through the sympathetic nervous system.